Primary cilia loss in bile duct cells- the interplay with the autophagy machinery

Project Summary/Abstract
Primary cilia are multisensory organelles that function as cellular antennae. We found that ciliary defects in
cholangiocytes and/or the loss of primary cilia are associated with biliary tract diseases like polycystic liver disease
(PLD) and cholangiocarcinoma (CCA). A better understanding of the signaling regulated by cilia and mechanisms
of ciliary loss in diseased cholangiocytes is critical to design new therapies based on the restoration of cilia, i.e.
ciliotherapies. Our current overall objective is to understand the role of cilia in the regulation of epidermal growth
factor receptor (EGFR) signaling. EGFR signaling is abnormally persistent and enhanced in PLD and CCA, two
diseases with ciliary dysfunction. Furthermore, we aim to explore the mechanisms of ciliary loss in cholangiocytes
– especially how the autophagy machinery is targeted to resorption of this organelle. This proposal will assess how
cilia-autophagy communication works in cholangiocytes to reduce ciliary expression and, consequently, how the
loss or dysfunction of cilia enhances EGFR signaling. We propose that pathologically-induced ciliophagy
accounts for ciliary loss/dysfunction, inducing sustained EGFR signaling. We propose three Specific Aims:
In Specific Aim 1: To characterize molecular mechanisms of the ciliary-dependent degradation of activated EGFR,
we will assess the need of cilia for activated EGFR degradation; characterize the mechanisms of EGFR
translocation to primary cilia; and assess the hypothesis that the E3 ubiquitin ligase c-CBL translocates to the
primary cilia upon EGF signaling and drives the degradation of activated EGFR located in the cilia. In Specific Aim
2: To identify the key players involved in targeting ciliary components to the autophagy machinery, we will assess
the role of autophagy and HDAC6/SIRT1 in ciliary expression in vitro; assess the role of HDAC6/SIRT1 in ciliophagy
in vivo; study the interaction between ciliary proteins and autophagy cargo receptors; and test the hypothesis that
in ciliary-defective cholangiocytes, overexpression of deacetylases induces lysine deacetylation of ciliary
components, which leads to ubiquitination of the same residues and targeting of the autophagy machinery by
specific autophagy cargo receptors. In Specific Aim 3: To test the combination of specific deacetylases,
autophagy, and EGFR inhibitors in pre-clinical rodent models as a therapeutic approach, we will assess the effect
of HDAC6 inhibition (Tubastatin-A or ACY-1215), and/or SIRT1 inhibition (Sirtinol) in combination with autophagy
inhibitors (e.g., HCQ, SAR405) with or without EGFR inhibition (Erlotinib, Afatinib) in vitro and in vivo; assess the
in vivo effects of Ciliomax (a novel dual inhibitor we recently developed) plus EGFR inhibition; and assess the most
promising treatments in patient-derived xenografts. Impact: identifying novel targets could lead to much-needed
new therapeutic strategies for these devastating diseases. Our experiments in in vitro and pre-clinical rodent
models will characterize the ciliary-dependent regulation of EGFR and the communication between primary cilia
and the autophagy process, which will lay the foundation for potential clinical trials.

Public health relevance
Project Narrative The main aim of this proposal is to develop new potential therapeutic approaches for polycystic liver disease and cholangiocarcinoma. Our proposed studies will uncover novel and generalizable information on the fundamental mechanisms of ciliary dependent regulation of EGFR signaling.